University of Michigan Postbaccalaureate Research Education Program (UM PREP)

PROJECT SUMMARY/ABSTRACT
The University of Michigan Postbaccalaureate Research Education Program (UM PREP) was inaugurated in
2009 to increase the ability of underrepresented students to successfully compete for admission to biomedical
research graduate programs and to succeed in obtaining doctoral degrees from excellent Ph.D. programs across
a broad range of biomedical disciplines throughout the country. Through a combination of NIH support and
institutional funds, UM PREP scholars will receive research training in: 1) biomedical sciences in the Medical
School (through the Program in Biomedical Sciences, comprised of 13 graduate degree-granting programs), 2)
biomedical engineering through the College of Engineering (including biomedical, chemical, mechanical, and
materials science engineering), 3) Chemistry, Chemical Biology, Molecular, Cellular, and Developmental Biology,
and Psychology in the College of Literature, Science, and the Arts, 4) Pharmaceutical Science and Medicinal
Chemistry in the School of Pharmacy, 5) public health disciplines, including Epidemiology and Biostatistics in
the School of Public Health, 6) the science of human movement in the School of Kinesiology, and 7) oral health
sciences, sensory biology and cancer biology in the School of Dentistry. The University of Michigan is committed
to recruiting a diverse and talented student population at all levels (from K-12 to undergraduate, and from
undergraduate to graduate and professional programs). This commitment has been highlighted by a major
diversity effort initiated by University of Michigan President Mark Schlissel (http://www.diversity.umich.edu). Now
in its fifth year, and led by Dr. Robert Sellers, Chief Diversity Officer, the University of Michigan has committed
85 million dollars to fund more than 2,500 action items from 50 plans developed by individual schools, colleges
and campus units. Since its inception in 2009, UM PREP has trained 107 scholars, and we are currently training
a cohort of 11 UM PREP trainees. Of these 107 UM PREP alumni, 83 matriculated in Ph.D. or M.D./Ph.D.
programs (77% Ph.D. matriculation rate). Of those 83 matriculants, 24 UM PREP alumni have successfully
obtained their Ph.D. degrees in biomedically relevant fields, while 47 UM PREP trainees are actively pursuing
their Ph.D. degrees (85% Ph.D. retention rate). Further, UM PREP alumni have been extremely successful in
obtaining individual fellowships with 10 NSF GRFP awardees, and five individual NIH predoctoral fellowships,
including a prestigious F99/K00 award. The continuation and expansion of the current, highly successful UM
PREP program at the University of Michigan, with support from the Medical School, College of Engineering,
College of Literature, Science, and the Arts, Center for the Education of Women+ (CEW+) and the Rackham
Graduate School will provide promising UM PREP scholars from around the country with the needed preparation
both to apply successfully to rigorous graduate programs and to succeed once they matriculate.

Public health relevance
PROJECT NARRATIVE This proposal will encourage individuals from diverse backgrounds, especially those that are underrepresented in biomedical science, to pursue careers in biomedical research. Since its inception in 2009, the Michigan Postbaccalaureate Research Education Program (UM PREP) has prepared over 100 scholars to successfully compete for admission to graduate programs across a wide range of disciplines, including, but not limited to Biochemistry, Bioinformatics, Biomedical Engineering, Biophysics, Cancer Biology, Cell Biology, Developmental Biology, Genetics, Immunology, Microbiology, Neuroscience, Pathology, Pharmacology, Physiology, and Neuroscience. In this renewal application, we will continue to enhance our efforts to prepare UM PREP trainees for success in graduate programs so that they can continue to make outstanding contributions as part of a diverse scientific workforce.